TREATMENT OF ALCOHOLIC FIBROSIS WITH PHOSPHATIDYCHOLINE

This study is designed to determine whether polyunsaturated lecithin, also known as PPC (polyenephosphatidylcholine), is effective in preventing cirrhosis (scarring of the liver) in high risk alcoholics patients.